Predicting Effects of ENDS Flavor Regulations Among Latinx/e Smokers: Impact of Cultural Assets on Attitudes, Intentions, and Behavior.

PROJECT SUMMARY. Smoking is a major contributor to lung cancer, which is the leading
cause of cancer death among Latinx/e men (13%) and the second leading cause after breast
cancer for women (10%). Little work has examined how electronic nicotine delivery system
(ENDS) uptake affects tobacco use and associated toxicity among Latinx/e smokers. Recently,
FDA began regulating closed-system devices like JUUL, which have captured over 70% of the
ENDS market and contributed to dramatic increases in youth ENDS use. As of early 2020,
flavored ENDS cartridges (a small, enclosed unit used as part of an ENDS) other than
menthol/tobacco are banned in the US. However, to achieve its public health mission, the FDA
must balance restricting access to ENDS flavors that appeal to youth with the need for evidence
on “whether and how certain flavors may help adult cigarette smokers reduce cigarette use and
switch to potentially less harmful products”. Understanding the potential of ENDS to reduce the
public health burden of combusted tobacco use equitably requires a targeted study to predict
how future ENDS flavor regulations will impact Latinx/e smokers. The current study will evaluate
whether ENDS flavor availability affects measures of tobacco use and investigate the
mechanisms of addiction among Latinx/e adult smokers (N=150) by performing a cross-
sectional study. The researcher will focus on the underserved Latinx/e community of Virginia
where there is a need for the availability of bilingual services. The study will be culturally
adapting one aim from the parent study (Predicting effects of ENDS flavor regulations on
tobacco behavior, toxicity, and abuse liability among African American menthol smokers) while
incorporating the possible implications of intersecting cultural factors on tobacco and substance
use. A battery of measures will be administered in English or Spanish during one in person visit
in Richmond, Virginia or via Zoom. Latinx/e communities are typically excluded from tobacco
research and underserved in health services, and substance use prevention. Many times
communities who may share marginalized experiences are grouped together in research which
ignores crucial differences between these groups. Results of this work will help the FDA make
predictions about the regulatory impact of ENDS flavor restrictions across multiple intersecting
identities of smokers. Answers to these questions will address FDA’s priorities in behavior and
addiction and will provide new data regarding the consequences of potential FDA regulatory
actions on flavor ENDS to help maximize health-promoting effects and minimize unintended
consequences among Latinx/e smokers.

Public health relevance
PROJECT NARRATIVE. Latinx/e smokers are disproportionately underserved by tobacco and substance use treatment and prevention and may experience important health benefits from well-regulated electronic nicotine delivery systems (ENDS). The current study will evaluate whether ENDS flavor availability affects measures of tobacco use, the intersection of cultural assets and factors, and overall addiction among Latinx/e smokers by performing a cross- sectional study. Results of this work will help FDA make predictions about the impact of moving from the current regulatory market where menthol/tobacco flavored ENDS cartridges are available to one where only tobacco or unflavored cartridges are available to maximize health- promoting effects and minimize unintended consequences among smokers with marginalized identities.